The 9th International Symposium on Middle Ear Mechanics in Research and Otology (MEMRO)

Project Summary We request in this proposal partial support to cover the expenses of the 9th International Meeting of the Middle Ear Mechanics in Research and Otology (MEMRO) 2021 conference, which will be held in June of 2021 at the University of Colorado's Boulder campus. Consistent with the goals of the first MEMRO meeting in 1996 the purpose of this triennial meeting is to bring together experts in middle ear science and engineering, with clinical otologists, in order to foster an exchange between these related but too often independent groups. Recent MEMRO meetings were held in Shanghai (2018) and Aalborg, Denmark (2015) and each attracted ~200 participants from over 20 countries. A goal of the 2021 meeting will be to continue to facilitate the free exchange of ideas between basic and clinical scientists, and to provide a framework for novel collaborative efforts in order to advance our clinical and scientific understanding of middle ear function, dysfunction and repair. The theme of the 2021 MEMRO meeting will be “Advances in Middle Ear Science and OTO surgery”, highlighting our focus on the intersection between the two fields. An important goal of this meeting is to increase diversity in the attendees. In particular, we intend to specifically target otology residents and faculty by hosting a “Middle-Ear Surgical Lab and Seminar” the day immediately prior to the formal MEMRO 2021 meeting. The 2021 MEMRO meeting is being organized by the University of Colorado School of Medicine and the meeting will be held on the nearby University of Colorado Boulder campus, chosen because of its convenient location allowing easy travel, idyllic campus and surroundings, and very reasonable costs with on- campus housing and dining options adjacent to the conference venue available for attendees.

Public health relevance
Project Narrative Repair of middle ear pathologies is one of the most common surgical procedures performed by ear surgeons and there is a critical need to improve our understanding of the mechanics of the middle ear in healthy and pathological ears. The planned conference will be of interest to basic scientists, otolaryngologists, engineers, as well as residents and students. Collaborations between these different groups of researchers and practitioners will, as has been shown to be the case in past meetings in this series, lead to improvements in diagnosis and therapy of middle ear diseases.